COACH: Competency Based Approaches for Community Health

PROJECT SUMMARY
Despite the recognition of health disparities in obesity, behavioral interventions among low-income and
minority populations have consistently met with limited success. This is partially explained by social
determinants of health. Barriers at the community level impede consistent engagement in healthy behaviors.
The proposed ancillary study adds objective community-level data and corresponding analyses to an ongoing
behavioral obesity intervention for low-income Latino families, entitled COACH (R01HD100458 from NICHD, PI
Heerman). By using a comprehensive measurement approach that considers the physical activity environment,
the food environment, the social environment, and the historical/structural environment, we aim to characterize
these complex and cumulative contextual risks for children enrolling in our ongoing COACH clinical trial.
COACH (COmpetency-Based Approaches to Community Health) implements a personally tailored
approach, equipping families to engage in health behaviors despite dynamic barriers. COACH is a multi-level
intervention targeting 1) the individual child through developmentally appropriate health behavior curriculum, 2)
the family by addressing parent weight loss directly and engaging parents as agents of change for their
children, and 3) the community by building capacity of Parks and Rec centers to offer parent-child
programming. Using novel multi-component assessments throughout the two years of the study, the
intervention identifies individual, family, and community barriers to healthy behaviors and delivers structured
yet personalized intervention content in 7 domains: fruits/vegetables, snacks, sugary drinks, physical activity,
sleep, media use, and parenting.
This ancillary proposal seeks to augment the data collection by adding key community-level contextual
variables to measure the moderating impact of those variables on the effectiveness of the intervention. We
propose collecting data related to urban density; food access, availability, and quality; multiple components of
the physical activity environment; and variables related to social inequality. We will combine data from 1)
prospectively conducting neighborhood and grocery store surveys and 2) local and national publicly available
datasets to identify individual-level assessments of community-risk that can then be incorporated into the
analysis plan for the main trial. In addition to conducting individual moderator analyses for each of the
variables, we will conduct a prospective cohort analysis to evaluate their cumulative impact on child BMI over
time.

Public health relevance
PROJECT NARRATIVE One-size-fits-all approaches have failed to demonstrate sustained effects on childhood obesity, especially among low-income minority families, who experience constantly changing barriers to engaging in health behavior. Addressing obesity in these populations requires intervening in early childhood and situating interventions in the context of families and communities. By using a comprehensive measurement approach that considers the physical activity environment, the food environment, the social environment, and the historical/structural environment, we aim to characterize how these complex and cumulative contextual risks for children are related to childhood obesity.